Dissecting the role of Notch signaling in mouse pre-implantation embryo development

PROJECT SUMMARY/ABSTRACT
During pre-implantation mammalian development, cells must make their first critical fate choice to specify the
trophectoderm (which forms the extra-embryonic placenta) or inner cell mass (which develops into the embryo
proper). To achieve this lineage commitment, the embryo coordinates the major mechanical changes of
compaction and polarization with critical signaling programs that drive cell fate. The role of Yap
mechanotransduction in guiding trophectoderm fate beginning at the 8-cell stage has been well-studied.
However, trophectoderm development is not driven by Yap signaling alone, but also requires activation of the
Notch pathway. While other developmental contexts provide insight into how Notch could interact with mechanics
and Yap to guide cell fate decisions, the role of Notch in mouse pre-implantation lineage determination remains
unknown. This proposal will elucidate how Notch integrates with Yap and mechanics to guide
trophectoderm specification and pre-implantation embryogenesis. I will investigate the central hypothesis
that Notch lateral inhibition starting at the 2-cell stage primes a subset of cells toward the trophectoderm lineage;
during polarization, Notch signaling could stabilize the apical domain to reinforce Yap signaling and maintain
trophectoderm identity through blastocyst morphogenesis. Historically, live cell dynamics of pre-implantation
embryo development have been challenging to study due to phototoxicity. However, recent advancements in
light-sheet microscopy, biosensors, and optogenetics allow us to visualize and perturb signaling dynamics with
unprecedented spatiotemporal resolution. I will harness this high-resolution imaging system to determine (1) how
Notch signaling relates to embryo mechanics and (2) how Notch and Yap signaling dynamics specify and
maintain trophectoderm fate. For the completion of these aims, I will gain training in advanced microscopy,
quantitative developmental biology, scientific communication, teaching, and mentorship. The expertise from my
sponsor, Dr. Orion Weiner, an expert in signaling dynamics and cellular mechanics, and support from the F31
NRSA will ensure that I receive the mentorship and resources necessary to complete my proposed research and
training plan. My work will reveal how the embryo integrates different modes of signaling with mechanics to guide
cell fate decisions. A better understanding how pre-implantation development is regulated will help advance
Assisted Reproductive Technologies and ameliorate infertility.

Public health relevance
PROJECT NARRATIVE Estimates suggest that over half of all embryos arrest development prior to implantation in the uterus, but we do not understand how pre-implantation development is controlled to prepare the embryo for implantation. In particular, it is not well understood how signaling and mechanics are integrated to specify the trophectoderm cell lineage, which mediates implantation and forms the placenta. This study aims to elucidate the understudied role of Notch signaling in guiding trophectoderm specification during mouse pre-implantation development, which will inform future advancements to stem cell-based embryo models and Assisted Reproductive Technologies.